GERIATRIC LEADERSHIP ACADEMIC AWARD

This is an application for renewal of the Geriatrics Leadership Academic Award (KO7). The overall objective is to promote aging research and education at the University of Texas Health Science Center at San Antonio by coordinating and expanding the gerontologic activities of our faculty and students. A result should be the enhancement of the quality and quantity of aging research and an increased ability of our faculty to compete for extramural funding for aging research programs from state, federal and private sources. The specific aims are: 1. To continue the program of elective courses in gerontology for students in our Schools of Allied Health Sciences, Dentistry, Medicine, and Nursing which were initiated during the 01 year of the award. 2. To provide course work on research approaches to the study of aging for graduate students, postdoctoral trainees and faculty of basic science and clinical science departments. 3. To provide faculty and postdoctoral trainees of the clinical and basic science departments with hands-on experiences in gerontologic research including the means to conduct pilot studies. 4. To continue programs aimed at catalyzing interactions between faculty working in gerontology with research groups in our institution working in areas related to gerontology. 5. To promote the development of the recently created Aging Research and Education Center of the University of Texas Health Science Center at San Antonio. 6. To provide the Principal Investigator with training in evolutionary and comparative biology of aging and in the genetics of aging.